Advancing Cancer Control Equity Research Through Transformative Solutions in Patient Navigation (ACCERT PN)

OVERALL – ABSTRACT
Chicago, one of the most diverse yet segregated cities in the US, is characterized by egregious cancer health
inequities. We propose to establish the Advancing Control Equity Research Through Transformative Solutions
in Patient Navigation (ACCERT PN) Center to develop community-engaged interventions, measures and
methods for process and outcomes assessment, and researcher and community partner capacity and
engagement centered around the theme of innovative multilevel patient navigation (PN) approaches and
implementation science within learning health systems to address structural racism and other Social
Determinants of Health (SDOH) with the goal of mitigating cancer health inequities in Chicago’s Black, Latinx,
and low-income Chinese communities. The ACCERT PN Center’s research program will commence in the first
year with the launch of a five-year signature SDOH Research Project and two rapid and responsive, thematically
linked Community Responsive Projects. The SDOH Research Project will leverage innovations in systems
engineering and artificial intelligence (AI) to develop and test two multilevel PN approaches via a Hybrid Type 2
randomized effectiveness-implementation trial. Community Responsive Project 1 will develop communication
strategies and training resources for navigators and healthcare providers on community-driven cancer
survivorship topics for Black women, such as sexuality after cancer, via the Truth Talking Tour. Community
Responsive Project 2 will explore the use of AI social robots in Chicago Chinatown community settings to
enhance digital literacy and cancer health literacy to inform the SDOH Research Project. Additional Community
Responsive Projects will be identified in subsequent years. Projects are supported by an Administrative Core
that will oversee operational and scientific activities as well as community and internal and external advisory
boards, and build capacity and engagement among scholars, including those from underrepresented groups in
the biomedical and behavioral sciences, and community partners to implement ACCERT PN interventions that
incorporate the lived experiences of those who face cancer inequities. A Research Methods, Measures & Data
Management Core will support the development, implementation, and evaluation of projects by developing
measures and methods, and assessing community-level SDOH, community engagement, and cancer control
equity processes and outcomes. This Center brings strong scientific rigor with significant potential to enact
transformative solutions to advance cancer control equity, as demonstrated by our focus on scaling and
transforming PN toward systems level care improvement to adequately close cancer care delivery gaps; a
diverse, transdisciplinary community-academic research team with exceptional track records in cancer control,
PN, SDOH, community engagement, implementation science, artificial intelligence, human-computer interaction,
systems engineering, community mobilization, and patient advocacy; and meaningful engagement with Chicago
communities and multisectoral community partners with the guiding North Star of “nothing about us without us”.
2

Public health relevance
The Advancing Cancer Control Engaged Research Through Transformative Solutions in Patient Navigation (ACCERT PN) Center will develop community-engaged interventions, measures and methods for process and outcomes assessment, and researcher and community partner capacity and engagement centered around the theme of innovative multilevel Patient Navigation approaches and implementation science to address language accessibility, health literacy, and other determinants of health – with the goal of mitigating low access to care and poor cancer health outcomes experienced by individuals from many Chicago area communities. The ACCERT PN Center’s research program will be supported by an Administrative Core and a Research Methods, Measures, and Data Management Core.